Genetic code expansion to improve the drug-likeness of hits from mRNA display

Project Summary. Many important drug targets including protein-protein interactions (PPIs) are still
intractable with modern drug discovery methods. In vitro selection technologies, in particular mRNA display,
have proven to be powerful methods for discovering macrocyclic peptides that target PPIs. The extreme
diversity of mRNA-displayed macrocyclic peptides (10s of trillions of individual peptides) allows rapid
generation of a high-affinity hit where other technologies fail. For this reason, mRNA display has been
increasingly employed as a tool for lead development in pharmaceutical companies worldwide. Unfortunately,
while these hits have high affinity for their targets, they typically greatly exceed even the most generous
beyond rule of 5 (bRo5) parameters for drug-likeness. This is because mRNA display relies on in vitro
translation to create the diverse libraries and is constrained in monomer diversity by the genetic code.
Therefore, accessing the high diversities required to identify hits built from 20 monomers requires random
regions of at least 10 residues (20^10 = 10 trillion). To get into the bRo5 space one needs to create shorter
peptides of <6 monomers, which are significantly less diverse (20^6 = 64 million). This proposal leverages our
expertise in in vitro translation to expand the genetic code in order to increase monomer set available for
mRNA display from 20 to >40, dramatically enhancing the diversity of short macrocyclic peptides within the
libraries (40^6 = 4 billion) . Our prior research shows that by combining hyperaccurate ribosomes and in vitro
transcribed tRNAs one can dramatically break apart the degeneracy of the code. Our first research goal is to
leverage these resources and tRNA engineering move as close to a one codon-one amino acid paradigm as
possible. A second research area also aims to build monomer diversity through the addition of unnatural base
pairs (UBPs). The goal is to show that at least 10 UBP codons are amenable to mRNA display, further
enhancing the potential monomer diversity. The third direction focuses on the creation of a strategy for
prioritization of monomers to use with a given mRNA-displayed peptide library. This will be achieved by first
screening for small molecule fragments that bind followed by appending these fragments onto amino acid side
chains within the library. The inclusion of known binding fragments as side chains will improve the affinity and
specificity of the downstream hits. Each of the three research goals will utilize model protein targets to validate
they are useful within the context of mRNA display. This research is expected to give new, valuable insights
into the malleability of the genetic code and the translation apparatus towards engineering. The research will
also enable the creation of diverse, bRo5 compliant libraries with monomers tailored to a given target, enabling
the downstream discovery of many new drug-like macrocyclic peptide leads to currently intractable targets.

Public health relevance
Project Narrative The proposed research aims to build a drug discovery system applicable to difficult protein targets for which traditional drug discovery has failed. The technology involves creating an engineered genetic code for the creation of diverse peptide libraries from which potential drug candidates can be found.